Development of upper extremity behavioral assessment methods for reach-and-grasp and physical rehabilitation

The overall goal of this proposal is to develop and advance behavioral assessment methods (BAM) to
measure spontaneous reach and grasp in infants and toddlers with and without hemiparetic cerebral palsy.
Reach and grasp are critical to promoting healthy development and active engagement with the environment.
This proposal focuses on the key period from 8 – 36 months of age when infants rapidly develop upper extremity
skills, mobility, cognition, and language; and when hemiparesis-specific treatments, such as constraint-induced
movement therapy, can be started. BAM will advance scientific knowledge about typical movements of the arms
and hands as well as altered movements in children with hemiparetic cerebral palsy. This will yield a
standardized, objective metric that quantifies the distance between impaired and typical development and will
expand the precise measurement of treatment-induced recovery. This project includes prospective longitudinal
data obtained from typically developing infants and toddlers and leverages video-sharing and support from
StrokeNet’s Phase III randomized controlled trial of constraint-induced movement therapy.
In AIM 1 we will develop the BAM Index using reach and grasp behaviors in 80 typically developing
infants/toddlers and 240 infants/toddlers with perinatal arterial ischemic stroke and hemiparetic cerebral palsy.
Videos will be coded for spontaneous reach and grasp frequency, duration, and exploratory behaviors with a
common set of objects. Multiple statistical models will be employed to develop four standardized BAM Indices.
In AIM 2 we will (a) evaluate the changes of four BAM Indices with 1040 longitudinal videos from the
cohorts and (b) establish psychometric properties of the BAM Indices using: the Pediatric Stroke Outcome
Measure (Neurological deficit and function); Gross Motor Function Measure-66 (Gross Motor), Bayley Scales of
Infant and Toddler Development 4th edition (Fine Motor, Gross Motor, Language, and Cognition subscales), mini-
and Assisting Hand Assessment (paretic hand); parent-reported outcome measures (Infant Motor Activity Log,
MacArthur-Bates Communicative Developmental Inventories); and a combined clinical/parent outcome measure
(Emerging Behaviors Scale).
This project has the potential to advance pediatric rehabilitation research by affording a novel, reliable,
precise, and sensitive measure of reach and grasp – applicable to hundreds of thousands of children with infant
stroke and hemiparetic cerebral palsy. Furthermore, the novel use of data sharing and video coding are
imperative for scientific reproducibility, reduction in cost, and will support the ability to improve health and
physical function in infants and toddlers with cerebral palsy and other physical disabilities.

Public health relevance
PROJECT NARRATIVE The proposed research is highly relevant to public health because it adds to our fundamental knowledge about reaching and grasping behaviors of the upper extremity in infants with and without hemiparetic cerebral palsy. The application of new measurement methods, knowledge about healthy and impaired spontaneous arm and hand use, and response to treatment will enhance health and help reduce disability for the millions of individuals of cerebral palsy and other physical disabilities who need rehabilitation. Thus, the proposed research is consistent with NIH mission that pertains to the development of fundamental knowledge to extend healthy life and develop translational clinical research to help reduce the burdens of illness and disability.